Olympus VS-120 Virtual Slide Scanning System

DESCRIPTION (provided by applicant): The virtual slide scanner and quantitative software is absolutely essential in allowing pathology truth to define imaging truth. We are funded through NIH grants to undertake this important task for lung and prostate cancer in the human. The proposed instrumentation, the Olympus VS120 slide-scanning microscope with VisioMorph newCAST software is critical for the completion of several very important NIH funded research projects and NIH funded educational grants at the University of Iowa. Some of the immediate applications include distinguishing malignant from benign lung nodules, 3D reconstruction imaging of mouse, ferret and pig lungs as a baseline for animal models in cystic fibrosis animals, defining the development of cystic fibrosis phenotype in the pancreas. The successful completion of Dr. Henry's research will lead to identification of patients at risk for lethal prostte cancer at stages early enough for effective treatment. Dr. Hammond seeks clarification of the role of inflammation in chronic pain leading to enhanced therapies for a higher quality of life for chronic pain patients. Dr. Dunnwald and Dr. Murray are analyzing the role of the protein Irf6 in immune cells associated with wound healing. Dr. Bonthius will test the efficacy of gene therapy against Alexander's disease, a disease with devastating and lethal affects on infants and children. The virtual slide scanner will also support the microscopy component of a current National Library of Medicine funded educational research and resource proposal that is aimed at increasing the efficiency and cost effectiveness of laboratory test ordering in clinical medicin. Updating and expanding the Virtual Slidebox for medical, dental and graduate students. The Virtual Slidebox increases accessibility, student satisfaction and efficiency of learning. This database is also used to assess the diagnostic competency of resident physicians. Enhanced medical student and resident education will continue to improve the lives and health of countless patients.